Evaluating environmental metals exposure on risk of LCH

PROJECT SUMMARY
Langerhans cell histiocytosis (LCH) is an inflammatory myeloid neoplasia characterized by an upfront
chemotherapy failure rate of 50%, leading to disease progression that results in considerable short-term
morbidity and significant late effects. LCH presents with a wide spectrum of symptoms, from self-resolving
single-organ lesions to potentially fatal disseminated multi-organ disease. LCH occurs throughout life, with a
median age at diagnosis of 30 months, and incidence of 4-8 cases per million children <15 years of age. While
the somatic mutational drivers for LCH have been elucidated, risk factors related to LCH susceptibility are not
well understood. In our R01, we are investigating the genetic mechanisms underlying the pathogenesis of LCH
and noted that the age-standardized incidence rates for LCH is higher among Hispanic children (0-19 years
old) compared to non-Hispanics. We also noted that genetic variation with SMAD6 may contribute to the
observed ethnic disparity in incidence of LCH. However, we cannot rule out the potential role of environmental
factors on susceptibility as Hispanics are also disproportionately exposed to environmental toxicants. In fact,
there is some epidemiologic evidence that exposure to certain environmental factors, including metals, may
contribute to risk of LCH. Several metals, including arsenic, cadmium, chromium, and nickel, are classified as
carcinogenic by the International Agency for Research on Cancer. Prior studies examining risk of metal
exposure and LCH were based on parental occupational exposure, which would misclassify those residentially
exposed, and did not specify the timing of exposure (i.e., prenatal or postnatal). To overcome some of these
limitations, studies of childhood leukemia have linked residential addresses at birth or diagnosis to sources of
pollutants and evaluated risk. However, no studies have leveraged geospatial information in relation to risk of
LCH. Furthermore, another limitation of self-reported or linkage to geospatial data is that the studies lack
objective measurements of specific metals. Deciduous or primary teeth are a novel, non-invasive, and readily
accessible exposure assessment matrix that can provide objective measurements on pre- and post-natal
uptake of environmental toxicants, including metals, and have not been adopted in studies of LCH.
Additionally, data from primary teeth have not been well characterized in relation to geospatial proximity to
environmental sources of toxicants. Our overall objective is to apply novel and underutilized exposure
assessment methods to our studies of LCH. The goal of this supplemental application to our funded R01 is to
conduct a pilot study to assess the feasibility of obtaining primary teeth as novel exposure assessment matrix
in studies of LCH and linking addresses to geospatial data. We hypothesize that primary teeth will overcome
the exposure assessment limitations of prior studies and be an excellent exposure assessment method to
expand to a larger study investigating environmental risk factors of LCH.

Public health relevance
PROJECT NARRATIVE Langerhans cell histiocytosis (LCH) is an inflammatory myeloid neoplasia characterized by an upfront chemotherapy failure rate of 50%, leading to disease progression that results in considerable short-term morbidity and significant late effects. As risk factors of LCH are poorly characterized, environmental epidemiologic studies using novel exposure assessment methods are critically needed to improve our understanding. This pilot study will assess the feasibility of collecting primary teeth to measure metal uptake and correlate their measurements with area-based and self-reported measurements in studies of LCH.